Enhancing Diversity in Genomics Education and Research (EDGER)

PROJECT SUMMARY / ABSTRACT
The proposed project entitled Enhancing Diversity in Genomics Education and Research (EDGER),
submitted to the Initiative to Maximize Research Education in Genomics: Diversity Action Plan (R25) program
within the National Human Genome Research Institute, aims to recruit and train twelve undergraduate students
each year for five years at Hampton University in Virginia. Based on the student demographics of the institution
(designated an HBCU), it is anticipated that all student participants will be African Americans, typically under-
represented in the genome sciences. By hosting mentored extracurricular and curricular education and research
opportunities during the academic year and summer, students will focus on comparative genomics, experimental
cell biology, multi-omics data analysis and career development skills.
To contextualize the evolutionary innovation of exceptional bone phenotypes, students will have an
opportunity to examine the genomes of multiple divergent species including the gorilla, moose, beaked whale,
walrus, ocean sunfish, bowfin, sea lamprey and brown hagfish (Aim 1). Revealing key genomic regulatory
elements will allow for the experimental manipulation of bone progenitor cells (mesenchymal stem cells) in
culture using essential nutrients, antioxidants, phytochemicals, epigenetic regulators, and polyphenolic
compounds hypothesized to influence bone formation in vertebrates, including humans (Aim 2). Extracurricular
research experiences during the academic year will reinforce curricular training by pairing each student with an
HU faculty member participating in the EDGER program and provide examples relevant to human health (e.g.,
bone formation, homeostasis, repair, and regeneration).
Collaborators at the University of Vermont (a research intensive institution with a genomics core facility
and expertise in genome sciences) will assist with genomic data collection, data analysis and student training.
Integrating the skills and data acquired during the academic year, students will participate in month-long summer
sessions focused on data analysis each morning (hosted virtually by UVM collaborators), and career
development skills in the afternoons (hosted locally by HU faculty) (Aim 3). In total, eight faculty mentors and
sixty students will be supported by the program to achieve the long-term goal of increasing African American
representation in genome sciences (or related biomedical) research careers.

Public health relevance
PROJECT NARRATIVE African American students are under-represented in genome sciences, in part, because of a lack of opportunities exposing them to research methodologies and related careers. The proposed program will expose under-represented students at Hampton University (an HBCU) to a broadly themed series of genome sciences activities aimed at: (1) enhancing computations skills relevant to human diseases, (2) increasing laboratory research experiences translatable to biomedical sciences, and (3) improving training platforms in data analysis, interpretation, and dissemination. Comparative genomic analyses of vertebrate genomes will be used as a framework for bone cell evolution/biology, cell culture methods will reinforce the potential for manipulating the behavior of bone forming cells, and integrated analysis of next-generation sequencing data will allow first-hand exposure to the entire process of scientific inquiry toward the overarching goal of placing our students into post- graduate programs that develop into productive genome sciences careers.